Novel roles of RNA modifications in the pathogenesis of pulmonary vascular remodeling and PAH

Pulmonary arterial hypertension (PAH) is characterized by progressive increase of pulmonary vascular
resistance and obliterative vascular remodeling that causes right heart failure and premature death. Given
the underlying molecular mechanisms of obliterative vascular remodeling remain enigmatic, current therapies
have not targeted the fundamental disease modifying mechanisms and hence only resulted in a modest
improvement in the morbidity and mortality. While several transcription factors and transcriptional co-
activators have been studied in the context of PAH, post-transcriptional regulations of mRNAs that can affect
expression of key proteins remain largely unexplored. RNA modifications including N6-methyladenosine
(m6A) have recently been discovered as essential regulators of gene expression. The m6A modification
controls RNA stability, transport, and translation and has been linked to human diseases such as obesity and
cancers. Despite its functional importance in various fundamental bioprocesses, studies of m6A modification
of mRNAs in PAH are lacking. Our Supporting Data show that expression of fat mass and obesity-associated
protein (FTO), a well-characterized RNA demethylase, is markedly elevated in pulmonary vascular endothelial
cells (ECs) of idiopathic PAH patients. Tie2Cre-mediated deletion of Fto in ECs (FtoTie2Cre) inhibited PH
induced by chronic hypoxia. Our mechanistic studies provide evidence that several PAH-causing genes are
potential FTO targets in human lung ECs. Furthermore, pharmacological inhibition of FTO in monocrotaline-
challenged rats inhibited pulmonary vascular remodeling and PH. Thus, we hypothesize that endothelial
FTO, as a major m6A eraser, acts as a key regulator of mRNA stability and accumulation of key PAH-causing
genes in ECs to regulate pulmonary vasoconstriction and vascular remodeling and thus is a novel therapeutic
target for PAH. We propose the following 3 Specific Aims. In Aim 1, we will define the fundamental role of
endothelial FTO in the pathogenesis of PAH. In Aim 2, we will delineate the molecular mechanisms underlying
FTO regulation of endothelial dysfunction leading to pulmonary vasoconstriction and vascular remodeling.
We will identify the key FTO targets in ECs and address the possibility of rescuing the phenotype of FtoTieCre
by novel nanoparticle-mediated in vivo EC-specific gene transfer. In Aim 3, we will explore the therapeutic
potential of FTO inhibitors including a repurposed FDA-approved drug in the treatment of PAH employing 3
complimentary animal models of PAH. Based on the clear clinical relevance of our novel findings, we expect
that the proposed studies have significant translational potential by delineating the molecular and cellular
mechanisms of endothelial dysfunction leading to pulmonary vasoconstriction and vascular remodeling,
identifying druggable targets, and exploring pharmacological agents that can pharmacologically
inhibit/reverse vascular remodeling and also inhibit vasoconstriction for the prevention and treatment of PAH
in patients. Thus, we believe the proposed studies have great translational potential.

Public health relevance
Project Narrative The overall objective of the proposed studies is to determine the role of endothelial FTO in the mechanisms of pulmonary vasoconstriction and vascular remodeling and thereby provide novel therapeutic approaches for effective treatment of PAH and promote survival.